Time course and predictors of progression to postpartum prediabetes and type 2 diabetes in HIV: a prospective longitudinal study of low-income Indian women

PROJECT SUMMARY & ABSTRACT
Candidate. Dr. Puja Chebrolu is a physician-scientist who has spent the past five years conducting research
on HIV and diabetes in India. She has conducted longitudinal research, developed strong scientific
collaborations with Indian scientists, trained an Indian research team, and authored 10 publications. She has
documented that HIV increases the risk of gestational diabetes (GDM). She hypothesizes that HIV will also
increase the risk of prediabetes (preDM) and type 2 diabetes (T2DM) development postpartum.
Career Development Plan. Dr. Chebrolu's immediate and long-term goals are the following:
1) Increase her understanding of HIV-associated diabetes epidemiology and pathogenesis.
2) Increase her skills in advanced biostatistics for longitudinal data
3) Obtain training in the conduct of clinical trials
4) Develop professional skills including leadership and mentorship
Dr. Chebrolu will develop these skills through coursework and implementation of her longitudinal study on time
course and predictors of progression to postpartum preDM and T2DM in women living with HIV and GDM.
Environment. The proposed research and training will take place at Weill Cornell Medicine (USA) and at
Byramjee Jeejeebhoy Government Medical College (India). Dr. Chebrolu's mentors have expertise that
encompass her goals. They have worked with her and each other previously.
Research. Over
data
two-thirds of women who develop GDM will progress to T2DM within 10 years.
suggests that HIV doubles the risk of GDM
Dr. Chebrolu's
, and is associated with increased risk of progression to T2DM.
The impact of HIV on postpartum progression to preDM and T2DM is not known. Preliminary data suggests
that South Asian women progress to T2DM faster than obese populations due to low baseline pancreatic beta
cell mass. HIV increases beta cell stress through multiple mechanisms and may further accelerate the rate of
progression to T2DM. Understanding
progression
its
the impact of HIV on the time course and pathophysiology of T2DM
will help inform the timing and type of interventions to prevent or delay progression to T2DM and
devastating sequelae.
Aim 1: Estimate the time to progression to postpartum prediabetes and T2DM in 180 women with a history of
GDM (60 women with HIV and 120 women without HIV). We will test for prediabetes and T2DM at 5 timepoints
over 2 years postpartum. This aim will test the hypothesis that hazard of progression to prediabetes or T2DM
will be significantly higher in women with GDM and HIV compared to women with GDM and without HIV.
Aim 2: Determine the effect of HIV on longitudinal beta cell function in women with a history GDM. The primary
hypothesis is that women with HIV and GDM will have a greater rate of decline in pancreatic beta cell function
over 2 years postpartum compared to women with GDM and without HIV.

Public health relevance
PROJECT NARRATIVE HIV and gestational diabetes both increase the risk of developing type 2 diabetes postpartum, but it is not known whether HIV adds to the risks brought on by gestational diabetes. I propose a longitudinal cohort study following pregnant women with gestational diabetes with and without HIV over 2 years postpartum to 1) determine how HIV affects the development of type 2 diabetes or its precursor, pre-diabetes and 2) characterize the longitudinal effect of HIV on beta cell function, which is a major contributor to the pathophysiology of type 2 diabetes. The results of this study will be used to develop lifestyle or pharmacologic interventions to prevent diabetes in South Asian women with and without HIV.